Pelvic Floor Disorders Network Clinical Site Application: The San Diego Pelvic Floor Consortium

PROJECT SUMMARY
The objective of this application is to highlight the San Diego Pelvic Floor Consortium (SDPFC) site
qualifications to continue in the next cycle of the Pelvic Floor Disorders Network (PFDN). The success of the
SDPFC in the PFDN has largely been due to our proven two-site model, which combines the strength of a
tertiary academic medical center (University of California San Diego – UCSD) and a large volume
community based health maintenance organization (Kaiser Permanente San Diego – Kaiser). Our site has
contributed meaningfully over the past three cycles by designing and selecting cutting edge clinical trials ideally
suited to this multi-centered, multi-disciplinary research network. We intend to continue to foster novel research
ideas and work collaboratively with the other clinical sites and the data-coordinating center to refine studies
ideally suited to clinical trials requiring large-scales and diverse populations. We boast a history of successful
concept development, experience in survey development and refinement, successful implementation and
recruitment for large-scale clinical trials, extensive experience in implementation of randomized trials of
behavioral and surgical interventions, and maintaining high retention rates and quality data. Our proposed
SMART design randomized trial of Transurethral Bulking Agent vs. Single Incision Sling (BASIS) represents an
innovative and timely study of novel treatment approaches for women with stress urinary incontinence. The 15
members of the SDPFC are a diverse group of urogynecologists and urologists with the depth and breadth of
scientific and clinical expertise necessary for the PFDN to continue advancing the field. Additionally, our site
has an established research institution, funded by the NIH sponsored Clinical & Translational Science Award,
with the full spectrum of resources and personnel available to conduct basic science, translational,
epidemiologic, behavioral, and clinical research across a diverse racial/ethnic community. The SDPFC is
poised to continue to recruit subjects into existing and upcoming trials at the highest levels. The intellectual
contributions, leadership experience, diversity and experience in collaborative research projects makes the
SDPFC ideal for this network.

Public health relevance
PROJECT NARRATIVE Pelvic Floor Disorders (PFD) negatively impact millions of women and are major a source of personal and economic burden. Identification of safe and cost-effective treatment strategies for PFD often requires large-scale, multi-centered, randomized trials to quickly and accurately assess outcomes in a diverse population. The investigators in the San Diego Pelvic Floor Consortium, in collaboration with the other sites and data coordinating center, are poised to remain leaders in development of innovative research ideas, maintenance of high levels of recruitment and retention of subjects in clinical trials, and presentation of results in prestigious venues.